INVESTIGATIONS OF CURVED DNA

DNA containing dA tracts are known to be curved on the basis of biological and gel electrophoresis studies. We have used the 600 MHz and 500 MHz spectrometers to investigate a duplex DNA containing dA sequences. The NOESY, ROESY, JPH and JHH data is being used to determine the structure of the DNA solution.